Administrative Supplement to U54 HD110347: Development of a Common Processing Pipeline and Visualization Tools for HuBMAP GeoMx Assays

SUMMARY
This Administrative Supplement request aims to collaboratively develop and test open-source, GeoMX data
visualization and analysis tools required to support research using this data. Members of the Pregnant Female
Reproductive Tissue Mapping Center (TMC) will collaborate with members of the HIVE at Harvard Medical
School to fill a current gap in GeoMX visualization tools by working closely to develop a visualization tool for
Nanostring GeoMx data based on Vitessce (Aim 1) and to support local visualization and configuration (Aim 2).

Public health relevance
NARRATIVE The goals of the UCSD Pregnant Female Reproductive Tissue Mapping Center (TMC) are to develop three- dimensional multiscale maps of the placenta, pregnant uterine endomyometrium and fallopian tubes, using the GeoMx platform, along with other single-cell/single-nucleus and spatial omics platforms. In this Administrative Supplement, the members of this TMC will collaborate with the members of the HIVE at Harvard Medical School to develop and test open-source GeoMX data visualization and analysis tools required to support research using this data. This project is relevant to public health because it will fill the current gap in GeoMX visualization tools and enable facile and standardized handling, analysis, and sharing of GeoMx data among data generators and users.